Towards Safer and More Effective CART Cell Therapy Through the Modulation of Myeloid Cytokines

PROJECT SUMMARY
Despite the impressive activity of chimeric antigen receptor T (CART) cell therapy in the treatment of B-cell
malignancies, the therapy is limited by the development of toxicities, including cytokine release syndrome (CRS)
and neurotoxicity, as well as by lower rates of durable responses. The in vivo expansion of CART cells is a
critical determinant of their antitumor activity as well as of the development of toxicities. Over the last 5 years,
we have focused our work on addressing limitations related to CART complexity, toxicity, and resistance. We
utilized companion dogs as a proof-of-concept model to test engineered allogeneic human CART cells as a
therapy for spontaneous disease including diffuse large B-cell lymphoma (DLBCL). We engineered canine
CD20-targeting xenogeneic human CART cells (T-cell receptor alpha (TRAC)- and beta-2 microglobulin (B2M)-
disrupted), developed and optimized a canine-specific lymphodepleting regimen, and tested the safety of
xenogeneic CART cells in healthy beagles. Then, to track CART cell fates and functions in real time in vivo, we
developed and recently published the utility of sodium iodide symporter (NIS) as a platform to detect CART cell
expansion, trafficking, and toxicity in mouse models. In this application, we propose to utilize our NIS reporter
system, novel canine lymphodepletion regimen, and established canine clinical trial expertise to test NIS+ human
CART cells in companion dogs. We hypothesize that 18F-tetrafluoroborate (TFB) PET imaging of NIS+ canine
CD20-targeting xenogeneic human CART cells is a sensitive strategy to detect CART cell rejection, expansion,
and trafficking to tumor sites in canine patients with DLBCL. To test this hypothesis, we have designed two
specific aims. In Aim 1, we will study the utility of TFB-PET imaging of NIS+ CART cells to measure CART
expansion, rejection, and trafficking in canine patients with DLBCL. We will determine how quantitative PET
signal (qPET) correlates with quantitative PCR (qPCR) measurement of the CAR transgene in peripheral blood
and lymph node samples. In Aim 2, we will determine how TFB-PET imaging of CART cell expansion and
trafficking correlates with their activity and toxicity. Completion of these aims will validate qPET imaging as a
non-invasive platform to study CART dynamics in canine lymphoma and provide additional rationale to propose
a first-in-human clinical trial of NIS+ CART cells in patients with lymphoma.

Public health relevance
PROJECT NARRATIVE Our goal is to develop novel strategies to prevent toxicities, enhance efficacy, and increase access to chimeric antigen receptor T (CART) cell therapy for the treatment of cancer. We have developed and optimized the use of sodium iodide symporter (NIS) as a platform to track CART cells by PET imaging in vivo in mouse models and have previously launched CART cell therapy pilot studies in companion dogs. We are planning to study the ability of PET imaging of xenogeneic NIS+ CART cells to detect their expansion, trafficking, activity, and toxicity in canine patients with spontaneous diffuse large B cell lymphoma.